Administrative and Data Management Core

ABSTRACT – ADMINISTRATIVE AND DATA MANAGEMENT CORE
The Administrative Core of the Stanford Brain Metastasis Consortium (BMC) is structured to enhance efficiency, quality, and productivity while promoting integrated and effective collaboration and communication among Consortium participants, network partners, our local community, cancer networks, and the public in general. BMC’s Administrative Core aims to minimize the administrative burden of Consortium activities and services, centralize statistical consultation (study design and data interpretation), cement integration of projects through regular meetings, communicate accomplishments to the community via Patient Advocates, and encourage metrics-driven continuous improvement of all Consortium functions.
We have unified brain and cancer experts in the singular goal of improving our understanding and treatment of brain metastases. To accomplish the above goal, we have: (1) designed an organizational structure that supports scientists in our integrated Projects, enhancing efficiency and productivity within both the BMC and greater Stanford University network; (2) established policies and practices that ensure accurate, data-based selfevaluation for continuous improvement, and developed communication channels with scientists, patients, and companies most likely to benefit from and build upon our results; (3) created a seed grant program driven by the underlying goals of quality, innovation, efficiency, and effectiveness.
In summary, the Administrative and Data Management Core will provide fully integrative administrative services for the management, communications, coordination, and financial administration of the BMC MetNet Center. The Core will ensure productive collaborations through efficient management, active reflection, and strong communication, leveraging the expert administrative and financial management resources of Stanford University, ensuring Stanford Brain Metastasis Consortium’s generation of outstanding, high impact research.